Hazardous Waste Worker Training Program

CPWR HWWTP Summary/Abstract
This application is being submitted by CPWR-The Center for Construction Research and Training (CPWR) in
response to the Funding Opportunity Announcement, RFA-ES-19-003, Hazardous Materials Worker Health
and Safety Training (U45), for a Cooperative Agreement to support the development of model programs for the
training and education of workers engaged in activities related to hazardous materials and waste generation,
removal, containment, transportation and emergency response.
CPWR is the 501(c)(3) non-profit construction safety and health research and training arm of the North
America's Building Trades Unions (NABTU), which represents 14 international/national building trades unions
and over 3 million workers. CPWR submits this application in coordination and cooperation with a training
consortium of 12 of these 14 international/national building trades unions representing workers engaged in
hazardous waste work at designated 1910.120 sites around the country and in other environmentally
hazardous work assignments. These unions are listed in the Overall Specific Aims section of this Application.
Our proposed program is national in scope, and our major objective is to prevent work-related harm by training
construction workers in how best to protect themselves and their communities from exposure to hazardous
materials encountered during hazardous waste operations, environmental restoration of contaminated facilities
or chemical emergency response. In partnership with our 12 building trades union training consortium, our
specific aims are: 1) train 5,820 students in 389 courses in Year 1 and 29,100 students in 1,945 courses over
five years; 2) continue rigorous evaluations of all training courses, to assess students, instructors, curriculum,
and outcomes; 3) conduct train-the-trainer programs to continue to grow the pool of trainers available across
the United States; and 4) continue training and education for current and veteran instructors.